Accessing the hidden biosynthetic capabilities of fungi

PROJECT SUMMARY FOR PARENT GRANT GM112739
Filamentous fungi produce a vast universe of secondary metabolites (SM) with biological activities that are of
central importance for progress in medicine and agriculture. For example, fungal SMs exhibit cytostatic,
immunosuppressant, lipid lowering, or antimicrobial properties. Rapid progress in sequencing the genomes
of filamentous fungi has revealed a very large number of putative biosynthetic pathways with no known
metabolites, suggesting a vast potential for the discovery of new compounds and activities. However,
significant impediments to full characterization of fungal BGC diversity exist: (a) many SMs are synthesized
by ‘non-canonical’ biosynthetic gene clusters (BGCs) not recognized by bioinformatic algorithms, (b) many
BGCs are not expressed in standard laboratory conditions (e.g. ‘cryptic’ BGCs), and (c) genes for some
biosynthetic pathways are not all clustered and involve more than one locus. Further, there is (d) little
understanding of the genesis of functional BGCs. Our recent results clearly indicate that non-canonical
BGCs reveal genuinely novel structures or unusual biochemistry, that specific fungal differentiation signals
induce global BGC expression and that “hot spots” of recombination generate BGC diversity. In this grant,
we will (i) characterize isocyanide synthase (ICS) BGCs, a recently discovered family of noncanonical
fungal BGCs not recognized by current software algorithms for which we have preliminary results
demonstrating new and exciting biochemistry, (ii) use a fungal differentiation signal for transcriptomic
identification of ‘invisible' BGCs across diverse fungal taxa and (iii) address the hypothesis that
genomic “hot spots” of recombination and horizontal transfer give birth to new BGCs. Based on the
premise that non-canonical gene clusters are particularly likely to produce chemical entities with a high
degree of structural and functional novelty coupled with two advances able to identify active BGCs and how
BGC are formed, our tool set of comparative transcriptomics, advanced endogenous and heterologous
expression platforms and a recently developed platform for comparative metabolomics will provide a wealth
of new structures, biosynthetic pathways, and biological activities through expansion of the biology, genetics
and chemistry of fungal BGCs. Moreover, insight into BGC genesis and identification of global BGC induction
signals present genuinely new processes to further the scope of fungal BGC discovery and functional
annotation.

Public health relevance
PROJECT NARRATIVE FOR PARENT GRANT GM112739 Fungal natural products or secondary metabolites (SMs) have been invaluable as platforms for developing front- line drugs. Many putative SMs have remained undiscovered because current methodologies often fail to detect the genes involved in their production. This work will advance methods for discovery of useful SMs and provide a functional blueprint for identifying fungal SMs.